Mechanisms of localized neuronal excitation with diamond Wireless Axon and electrical microstimulation

Project Summary: This BRG R01 (PAR-22-242) application, a competing renewal of a previous PAR-16-242
submission, aims to significantly enhance the spatial and temporal resolution of intracortical microstimulation—
a crucial element in basic neuroscience research and human neuroprosthetics. Current challenges with
penetrating electrical stimulation arrays, tethered to the skull, include chronic issues such as mechanical
mismatch, neural degeneration, infection risks, mechanical trauma-induced failure, electrode position shifts,
axonal activation preference, and increased electrical impedances from glial scarring. These challenges
compromise the effectiveness of electrical stimulation, making longevity a formidable issue, with compensatory
increases in electrical current posing risks of permanent tissue damage.
This proposal introduces an innovative strategy that utilizes advanced biocompatible materials to develop
ultra-small, untethered Diamond "Wireless Axon" electrodes for electrically excitable tissue stimulation compared
to conventional and novel electrical stimulation parameters. The project aims to uncouple the mechanical
constraints inherent in traditional microstimulation technology, enhancing the spatial selectivity of activated
neurons for stable, long-term electrical stimulation. The guiding hypothesis posits that decoupling the mechanical
tether will improve tissue integration. The project aims to enhance spatial selectivity and longevity by decoupling
mechanical constraints in traditional microstimulation technology. The study investigates electrical
(faradaic/pseudocapacitive) and photovoltaic (capacitive) stimulation parameters, focusing on improving
electrode-neuron signal coupling and enhancing stimulation selectivity for neuronal somas.
The project will establish the foundation for Diamond Wireless Axon electrodes, considering varying boron
doping, micro (MCD) and nanometer (NCD) diamond sizes, and diverse packaging. Benchtop experiments will
measure photovoltaic and photothermal properties, identifying safety limits. Wireless Axon stimulation will be
quantified, and strategies explored to insulate conductive boron-doped diamond, anticipating superior
biocompatibility.
This comprehensive project addresses both mechanical and stimulatory aspects, aiming to develop advanced
neural probes for long-term, high-quality, and selective neural stimulation. Outcomes could lead to paradigm
shifts in neuroscience and clinical neuroprosthetics, offering the capability to activate specific neurons with
precision. Anticipated impacts include new paradigms for enduring neural interfaces and longitudinal probing of
neural circuits, benefiting both the research community and clinical scientists.

Public health relevance
Project Narrative This research project aims to engineer brain stimulation technology (hardware and stimulation code/software) for better understanding and treating neurological conditions. By developing small, untethered Diamond "Wireless Axon" electrodes, the study seeks to enhance precision and longevity in stimulating specific brain cells. If successful, this could lead to significant advancements in neuroscience and clinical treatments for conditions like paralysis or neurological disorders.